Novel methods for large-scale genomic interval comparison

ABSTRACT
This administrative supplement creates AI/ML-ready resources for epigenome genomic interval data.
Epigenome data summarized as sets of genomic intervals are now available for thousands of variations of cell
type, disease, condition, etc. This data holds tremendous promise to understand gene regulation and disease be-
cause many health outcomes are affected by genetic variation or epigenetic perturbation in regulatory DNA. The
parent R01 develops novel, scalable algorithms and measures of similarity between genomic interval datasets.
These advances will improve both the efﬁciency and accuracy of existing biomedical research approaches that
rely on analyzing genomic region data. They will open the door to new ways of exploring the vast and growing
corpus of genome interval data.
In this administrative supplement, we seek to take this rich data source and produce AI/ML-ready resources for the
community. While there has been some effort to create uniformly processed databases of genomic interval data,
there are few high-quality genomic interval currently available that are designed for machine learning applications.
One of the ﬁrst steps to integrating epigenome data across data sources is deﬁning consensus regions that
ﬁt the original data well. Many downstream analyses, particularly learning tasks, rely on such a consensus
region set. However, choosing a good consensus can be a time-consuming and confusing process, and also
has potential to lose substantial information and introduce errors into results. To help alleviate this challenge,
this proposal will take several datasets through a principled approach to generate AI/ML-ready resources. This
process will include 1) deﬁning consensus regions; 2) projecting raw data into the consensus to standardize it;
and 3) standardizing annotation. Finally, we will make these available to the community with user-friendly and
well-documented interfaces. The outcome will be a series of datasets that are ready for use for the community to
build ML models.

Public health relevance
Our goal is to support biomedical analysis of genome and epigenome data by developing faster and more accu- rate approaches to compare genomic interval sets.